Maternal exposure to chemicals and offspring neurodevelopmental disabilities: informing public health actions by understanding nutritional modifiers and simulating interventions

Project summary
Humans are ubiquitously exposed to metals and per-and polyfluoroalkyl substances (PFAS), which are either
established or suspected neurotoxicants in experimental and population settings. Exposure to these chemicals
can be particularly harmful in utero, a critical period of fetal brain development. Four major literature gaps exist:
1) prospective studies of in utero exposure to these chemicals and child risk of neurodevelopmental disorders
(NDs) are limited in the U.S, with most studies from predominantly White, European populations; 2) despite
growing evidence that these chemicals may affect multiple NDs and systems, most studies are limited to a
single ND outcome without consideration of comorbidities; 3) exposures rarely occur in isolation, yet combined
exposure across different chemical classes remain unclear let alone chemical-nutrition interplay (nutrition may
modify chemical toxicities); 4) most children’s environmental health studies focus on identifying risk factors with
few that use or develop solution-oriented analytic methods that can directly inform public health actions. To fill
these critical gaps, Dr. Choi proposes to investigate metals and PFAS in relation to clinician-diagnosed NDs
considering comorbidities, while examining nutritional modifiers that may mitigate chemical toxicities and
generating policy-relevant effect estimates via simulating intervention effects on chemicals and nutrition. To
address this overarching goal, she will leverage rich existing resources (biospecimen data and clinical
diagnoses of NDs and comorbidities across the lifespan) in the Boston Birth Cohort, a large prospective birth
cohort with a significant representation of understudied low-income minorities. In K99, Dr. Choi will estimate
the relations of metals and PFAS in maternal blood collected 24-72hours postpartum with NDs and
comorbidities in offspring (Aim 1). Comorbidities will be considered with cluster analysis, to evaluate whether
children with certain NDs and comorbidities are more vulnerable to the toxic effects of gestational chemical
exposures. She will receive interdisciplinary training across NDs & comorbidities, chemical-nutrition, research
translation, and advanced statistical methods (i.e., cluster analysis, mixtures analysis, causal inference) from a
multidisciplinary mentorship team and via additional training activities including coursework, seminars, working
groups, research dissemination activities targeted at lay audiences and policy settings, and national and
international workshops or conferences. In R00, she will evaluate nutritional modifiers of the adverse chemical-
ND relations identified in Aim 1 (Aim 2) and simulate intervention effects by estimating the number of NDs that
could have been prevented had there been pregnancy interventions on chemicals, nutrition, and both
chemicals and nutrition (Aim 3). This K99/R00 will position Dr. Choi as an innovative, independent researcher
in environmental epidemiology, with a unique niche in NDs and comorbidities, chemical-nutrition interplay,
research translation, and advanced methods. Our findings and activities will increase public awareness and
serve as scientific evidence for future policies on the environment or nutrition to reduce the burdens of NDs.

Public health relevance
Project narrative Metals and PFAS are neurotoxic, however, the effects of gestational exposure on neurodevelopmental disorder diagnoses and relevant comorbid conditions remain unclear let alone how to minimize chemical toxicities on human health. This study will investigate the roles of these chemicals and nutritional modifiers on children’s neurodevelopmental disorders and comorbidities, and predict effects of hypothetical interventions to reduce chemical neurotoxicity. Our findings will inform interventions and policies to promote children’s mental health and well-being.